Administrative Core

Project Summary
The overall goal of the Puerto Rico IDeA Network of Biomedical Research Excellence (PR-INBRE) is
to augment research capacity in Puerto Rico at the Lead and Network institutions by enhancement of the
research infrastructure, providing support for meritorious research projects and providing research experiences
for undergraduate and graduate students, post-docs, and early career investigators. In this renewal application
the University of Puerto Rico Medical Sciences Campus (UPR-MSC) will act as the Lead institution of the PR-
INBRE. The Administrative Core at the UPR-MSC will provide administrative support and scientific
assessment to the network. The goal of the Administrative Core (AC) in the next five-year cycle will be to
provide the organizational governance structure necessary to guide the PR-INBRE Program in the successful
execution of the overall program goals and the specific aims of this renewal proposal. These aims will be
achieved by overseeing the implementation of dynamic research opportunities for faculty, students and
postdoctoral associates, training activities for technical instruction and professional development, and
enhancement of research and teaching infrastructure at the PR-INBRE network institutions. The
Administrative Core will also oversee the continuous internal and external evaluation of these activities. This
includes implementation of changes that may be required by recommendation of the External Advisory
Committee and the External Evaluation and Tracking consultants of the program.